Evaluation of a Carepartner-Integrated Telehealth Rehabilitation Program for Persons with Stroke - NICHD K-23

? DESCRIPTION (provided by applicant):

Public health relevance
PUBLIC HEALTH RELEVANCE: Family members are key component in stroke recovery; however, care partners frequently experience high levels of burden, including increased anxiety, depression and social isolation. To date, research has placed little emphasis on how to integrate the family into the rehabilitation process without increasing negative care partner outcomes. The proposed research will evaluate a novel, care partner focused intervention (CARE-CITE) designed to foster problem solving and skill building while facilitating care partner involvement in the application of constraint-induced movement therapy (CIMT) for the upper extremity. PUBLIC HEALTH RELEVANCE: The overall significance of this research plan is to increase understanding and further development of interventions that may serve as models in rehabilitation to foster family involvement in the rehabilitation process and to promote more integrative therapy strategies throughout physical therapy practice.